High Efficiency Sorption System for Removing Harmful Contaminants from Indoor Air

Project Abstract
According to the EPA, indoor levels of pollutants are often 2-5 times and up to 100 times higher than
outdoor levels and people spend ~90% of their time indoors. The primary causes of poor indoor air quality
are pollution sources that emit irritating or dangerous gases and particles. The sources of indoor air pollution
can be fuel burning appliances, cooking and cigarette smoke, household cleaning items, and outgassing of
organics from building materials and furniture. Exposure of these indoor pollutants can result in
compromised health and occasionally even death.
In this Phase I SBIR project, TDA Research (TDA) will address this need by developing a high efficiency
adsorption system for removing contaminants/toxins commonly found in indoor air including HCN, NH3,
NO2, CO, and VOCs to sub ppb levels (well below the EPA permissible exposure level to comply with
WHO recommendations to reduce the incidence of cancer) to achieve risk based indoor air-standards. Our
system will feature a proprietary sorbent that offers superior adsorption capacities for common
contaminants such as VOCs (including formaldehyde and in particular chlorinated compounds), and NO2,
and with estimated lifetimes of 2-2.5 years, much greater than those offered by current devices that have
activated carbon filters that need to be changed every 3-12 months. Our system will also feature a long-
life ambient temperature catalyst that will be used to oxidize dangerous carbon monoxide into CO2 (a
feature currently not offered by current systems in the market).

Public health relevance
Project Narrative Typical indoor air pollutants include CO, VOCs, nitrogen oxides, benzene, and formaldehyde. As people spend ~90% of their time indoors, the EPA considers indoor air pollution to be one of the top five environmental risks to public health (EPA 2019). Particularly important are chlorinated VOCs, which are known to increase the risk of cancer from 1 in a million to 1 in 100,000 at 4 ppb, typical concentrations observed in indoor air (WHO Guidelines for Indoor Air Quality: Selected Pollutants 2010). Our technology will reduce the high risk VOCs and other common pollutants to less than 4 ppb to reduce health risks.